Epigenetic Regulation in Aging and Alzheimer's Disease

ABSTRACT
Alzheimer's disease (AD) is a progressive neurodegenerative disorder characterized by memory loss and
neuropathological changes in the brain. Aging remains the single largest risk factor for sporadic AD, but the
mechanisms underlying this risk are not well understood. Epigenetics has been implicated in both aging and the
pathogenesis of AD. Promising results from our group and others have showed that epigenetic alterations occur
during aging and thereby affect neuronal function, as well as contributing to memory deficits and the
pathogenesis of AD. In the proposed project, we will use mouse models of both aging and AD, as well as human
postmortem tissues, to determine the histone modifications in the epigenome that occur during aging. We will
also determine whether these changes promote the development of neuropathological changes that are
associated with AD. Our hypothesis is that dysregulations of histone modification during aging promote AD by
initiating the development of AD-related changes in neuronal networks at the molecular level. In turn, we also
hypothesize that histonedeacetylase (HDAC) inhibitorscan mitigate or even prevent the neuropathogenesis of
AD. To test our hypotheses, we will first map histone modifications that occur at three critical life stages (3, 12
and 18 months of age) in both wild-type (WT) and APP/PS1 mice, as well as human postmortem tissues (AD
patients, young, aged healthy controls), to determine whether differential histone acetylation and methylation
contribute to memory deficits and neuropathological changes associated with AD. This will be achieved through
CUT&RUN seq and RNA seq combined with pathway analysis to determine the functional consequence of
significant genes that are regulated by epigenetics. We will also profile histone modifications at specific gene
promoter regions that are related to memory, synaptic plasticity, and the typical elements of AD neuropathology.
Second, given that HDACs are key factors in histone modification and in the regulation of gene transcription, we
will determine whether dysfunction of any specific HDACs causes memory deficits in AD mouse models. For this
purpose, we will utilize genetic editing tools including CRISPR/Cas9-mediated knock-down and AAV9-eGFP-
mediated
over-expression
to identify critical HDACs (eg. HDAC2 and 3) that modulate histone acetylation and
methylation marks at gene promoters specifically linked to memory and neuronal plasticity. Finally, we will
determine whether HDAC inhibitors have beneficial effects on memory-like behaviors and AD-like
neuropathological changes in APP/PS1 mice (3, 12 and 18 months of age) as well as in age-matched WT mice.
More specifically, we will investigate whether non-selective (i.e., VPA) or selective HDAC inhibitors (i.e., MS-275
and CI-994) are effective in preventing and/or rescuing memory function and neuronal changes in aging and AD
mouse models. Overall, this project will significantly improve our understanding of the epigenetic mechanisms
that link aging with the neuropathogenesis of AD. Identification of these mechanisms will lay the basis for
developing novel therapeutic strategies for the prevention and treatment of AD.

Public health relevance
Project Narrative The Alzheimer's disease (AD) is a progressive neurodegenerative disease, and the age is a major factor for the most case of AD, but the mechanisms underlying the link between age and AD is still unclear. In this project we will use mouse models and human postmortem tissue to examine a novel epigenetic mechanism that effects on aging and AD, and whether changes of epigenetic regulation in aging could steer normal aging toward AD development. The information derived from the project will help to develop new prevention and treatment strategies that benefit AD patients.